Respiratory mucosal immune development in early life and the quest for protective local memory against respiratory syncytial virus.

PROJECT SUMMARY
Globally, respiratory syncytial virus (RSV) is the single most important pathogen causing lower respiratory tract
disease in the first year of life, and for which there is no vaccine. Previous vaccine strategies resulted in severe
RSV disease in infant vaccine recipients upon primary infection. Over the past 60 years subsequent vaccines
have failed. We, therefore, developed a neonatal murine model of RSV to interrogate the respiratory mucosal
immune response against RSV. Our overarching goal is to identify age-dependent immune regulation of mucosal
adaptive immune cells that results in susceptibility to RSV and can be targeted to precisely design vaccines for
infants. Tissue-resident memory T cells have recently been discovered to provide sterilizing protection against
influenza by rapidly responding to infection. CD8 T cells are critical for RSV clearance in murine models and are
associated with reduction of virus and reduced symptomatology in humans. Our research and that of other show
that neonatal CD8 T cell responses are often reduced compared to adults and poorly differentiate into memory
cells. How RSV-specific tissue-resident memory T cells (TRM) develop in infants and if they can be induced to
provide protection is unknown. Prior vaccines have not targeted this newly discovered T cell subset and they
have not been explored for vaccine design. Our central hypothesis to be tested is that neonatal RSV-specific T
cells poorly differentiate into TRM resulting in poor protective immunity, but that enhancing innate immune
activation can improve neonatal RSV-specific T cell localization to the respiratory mucosa and establish
protective RSV-specific TRM. Three Specific Aims are proposed to test this hypothesis, with the goal of identifying
novel immune targets for RSV vaccines designed for neonates. The proposed innovative experimental
approaches are designed to: (1) identify the requirements of the neonatal innate immune response to provide
antigen and/or T cell activation to establish RSV-specific TRM, (2) identify the subspecialized antigen presenting
cells that induce RSV-specific TRM and how to enhance APC activation to retain RSV-specific memory CD8 T
cells in the respiratory mucosa, (3) define the role of RSV-epitope specific TRM to protect against RSV infection.
These studies will define the key components of vaccine design including antigen availability and the critical
antigen presenting cells to target in order to develop RSV-specific TRM in neonates that protect upon challenge.

Public health relevance
PROJECT NARRATIVE Poor understanding of early life immune development has resulted in failed RSV vaccines over the last 60 years. Lung-resident memory T cells that reside at the mucosal surface have recently been discovered to provide rapid responses against respiratory viruses, however, they have not previously been evaluated for incorporation into neonatal RSV vaccines. We have recently discovered a strategy to induce protective neonatal RSV- specific tissue-resident memory T cells and an in-depth analysis of tissue-resident memory T cell development in neonates will generate new opportunities for precision vaccine design for young infants.